Modeling and Interacting with the Visible Molecular Cell

PROJECT SUMMARY
Integrative structural modeling of entire cells is a grand challenge actively being addressed by the structural
biology community. The complexity and heterogeneity of structural models of entire cells poses several
distinct challenges that are testing the current limits of technology and understanding. To tackle these
challenges, we are developing the CellPACK Suite, a functional prototype of an entire integrative structural
modeling pipeline. This pipeline allows users to gather and curate data from proteomics and structural
databases, and to integrate this data into representative structural models that can be used for hypothesis
generation and in-­silico testing. Our goal is to continue to develop, enhance, and harden this software, and
to continue the application and validation of mesoscale modeling methods to biomedically relevant problems.
The development will be driven by multiple collaborations with experimental and computational biologists with
a focus on using mesoscale models to interpret and validate tomographic data, and on functional modeling
of nucleoid structure in the context of entire bacterial cells and mitochondria. Throughout this work, we will
work in the classic integrative structural biology mode, building models to interpret and reconcile 3D
experimental tomographic data, and using models to infer the detailed molecular structure within tomographic
data sets of limited resolution. We plan to expand and harden our growing toolbox for structural integrative
modeling by developing new methods to incorporate specific interactions between molecules and working to
increase the range of systems that are achievable. We are also committed to creating user-­friendly and
targeted tools for the wider biological community and have created prototypes of software that allow facile
model creation and hypothesis-­testing by non-­expert users. My laboratory brings 30 years of experience in
gathering and integrating diverse biological data to depict the cellular mesoscale, and in the past 10 years,
development of quantitative approaches to modeling the cellular mesoscale as computational infrastructure
has progressed to the level where this is possible. Throughout this work, we have taken a practical, but
exploratory, approach to methods development, building novel tools to address the underlying questions
posed by our experimental collaborators, and then hardening the most effective tools to make them accessible
to the larger computational biology community. We intend to create an accessible and effective toolbox for
integrative modeling at the cellular mesoscale, driven by collaborative applications that span from atoms to
cells.

Public health relevance
PROJECT NARRATIVE We are creating user- friendly and targeted tools to create hypothesis- driven models of entire cells that integrate the large body of available knowledge on cellular composition and biomolecular structure. In collaboration with experimental and computational biologists, we are applying these methods to systems of biomedical interest, with a focus on the interpretation of tomographic data and modeling and simulation of bacterial and mitochondrial genomes. Integrative structural biology also provides unparalleled opportunities for outreach and education by providing a comprehensive and intuitive understanding of living systems that spans from atoms to cells.